Genetic dissection of dementia

Project Abstract
The major goal of this research is to identify the genetic risk factors with functional significance to
dementia in the model organism Drosophila melanogaster. The key aspect of dementia is age-
dependent neurodegeneration that cripples executive functions (e.g. inhibitory control) and
memory. Most dementia studies have focused on memory loss, which is a prominent symptom of
AD - the most common dementia type. While animal models have provided important insights into
the mechanism for memory loss, their utility for dementia gene discovery is limited since the study
of memory loss is time-consuming and laborious. Executive deficits are major symptoms in early
stage AD and related dementias yet largely understudied. We overcome these limitations by
studying inhibitory control deficit as a dementia endophenotype for the discovery of dementia
genes, which is innovative. Our approach is to conduct an unbiased screen for the genetic loci
causing dysfunctional inhibitory control in an age-dependent manner, with or without the non-
genetic risk factors. In this proposal we will also test the hypothesis that the genetic and non-
genetic risk factor interaction has a greater effect on dementia than a genetic factor alone.
Drosophila is tractable for student research training and education as it is easy to handle, allows to
readily apply state-of-the-art tools and approaches, and is cost-and time-effective. There is
currently no other biological research on dementia at UTEP. Dementia prevalence is
disproportionately higher in Hispanics than white Americans thus this study will not only promote
research relevant to our students and community but also increase the representation of Hispanics
in neuroscience research that is disproportionately low at present.

Public health relevance
Project Narrative Alzheimer’s disease and other dementias are chronic and progressive diseases without cure, imposing a huge health economic burden in our society. The proposed research is directed at advancing our knowledge of dementia etiology, which would facilitate the development of new prevention and therapeutic strategies.